The responsiveness of ILC2s in allergic airway inflammation

Project Summary
Allergic airway disease is one of the leading health problems in the USA and the world, and there are only limited
treatment and prevention methods. A better understanding of the pathogenesis remains critical for developing
efficacious treatment. Studies have shown that immune infiltrates, especially T helper (TH) 2 cells, play crucial
roles in pathogenesis. In addition to TH2 cells, group 2 innate lymphoid cells (ILC2s) are an important driving
force of allergic responses, which is, at least in part, by promoting TH2 cell development. Therefore, restriction
of the responsiveness of ILC2s may achieve a therapeutic purpose. Despite many studies on the induction and
functional promotion of ILC2s, there is little understanding of the negative regulation of these cells, which can be
one of the directions to manipulate them. The proposed studies will address this knowledge gap and elucidate
the mechanisms underlying the counter-regulation of allergic airway inflammation via regulating the
responsiveness of ILC2s.
Our previous studies have identified the cytokine signal suppressor Cytokine Induced SH2 protein (CIS or CISH)
as a key regulator that negatively controls TH2 (and TH9) responses and inhibits allergic airway inflammation.
Mice deficient in Cis spontaneously develop chronic airway inflammation during aging, resembling human adult-
onset allergic asthma; however, mice with T cell-specific Cis-deficiency do not develop a similar disease,
suggesting that additional cell types other than T cells with Cis-deficiency play a critical role in the development
of the spontaneous disease. Recently, Kotas et al. demonstrated that CIS constrains intestinal ILC2 responses.
In line with this, we showed that CIS restricts pulmonary ILC2 responses (preliminary results). Although lacking
mechanistic insight, the above observations lay the groundwork for our current research. The current proposal
will address a novel hypothesis that CIS serves as an essential checkpoint in ILC2s to restrict pro-allergic TH
cell differentiation, leading to the suppression of allergic airway disease.

Public health relevance
Project Narrative Allergic asthma is one of the leading health problems in the USA and the world, and there are only limited treatment and prevention methods, warranting further studies. In this proposal, we will investigate the essential role of the signal suppressor CIS in negatively controlling the development of a subset of pro-allergic cells, termed ILC2s, and aim to validate a novel conception that the CIS-ILC2 axis serves as a critical checkpoint in the development of allergic asthma. The results will provide novel insights into the pathogenesis of allergic asthma and potentially suggest new therapeutic options.